ENTERAL GLUTAMINE AND PRESERVATION OF BODY PROTEIN

The overall purpose of these studies is to test the hypothesis that glutamine has a protein anabolic effect in humans. Although Glutamine is the most abundant amino acid in the body, and can be synthesized de novo, muscle free glutamine pool if often observed in life-threatening conditions associated with protein wasting. In our recently completed studies, we have been able to demonstrate that acute administration of oral glutamine in fasted adults, increases whole body protein synthesis and also attenuates the protein wasting effects associated with glucocorticosteroids. These studies are conducted at the Nemours Children's Clinic in Jacksonville, Florida.